Authentic Literacy and Language (ALL) for Science

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The Authentic Literacy and Language (ALL) for Science partnership is developing curriculum materials to authentically engage elementary school students in how scientists use language, while building students’ science knowledge and skills. Building on a previous project with demonstrated results with students in grades 2-3, ALL for Science is creating four curriculum units for students in grades 4-5 that integrate standards aligned life science topics, with development of students’ science specific subject-area literacies, numeracy and related health content. Science themes for the units focus on areas of low student performance in life science and reading/writing in Texas. The project will engage a team of teacher leaders, scientists and educators to develop four Texas standards- and NGSS- aligned curriculum units, each designed to provide 3–4 weeks of life science inquiry-based instruction in school or as a blended school and home approach, with aligned reading/English language arts, health and numeracy. The curriculum units and supporting materials will be piloted in Texas classrooms; field tested through well-matched comparison group studies, with random assignment of groups; and disseminated via the established, high traffic website, BioEd Online, and through other pathways to reach state and national audiences with high quality, free teaching resources. The project directly will impact approximately 285 teachers and 6,840 students, with availability to teachers of more than 800,000 Texas students and national audiences. In addition, Houston-area elementary schools will serve as longitudinal implementation sites to gauge impacts on student achievement and formation of science identity, and teacher practices, while informing continued project improvement and local dissemination. We will measure changes in teaching practices and science teaching efficacy beliefs; and will examine growth of students’ content knowledge and science-specific reading and writing. This project responds to the SEPA program call for innovative curricula that will prepare students in STEM and enable their teachers to provide instruction using a novel approach. It addresses two of the three new areas of high programmatic interest: embedded math and reading content and adaptations of successful SEPA programs with new populations.

Public health relevance
The project provides a novel framework for integrating science inquiry with reading/English language arts (ELA) for students in grades 4-5. The strategies employed are designed to prepare students for future careers in science and health, develop science and health knowledge, and meet needs for a skilled workforce in public health and related fields.